An integrative approach to identify biomarkers and investigate mechanisms of adverse drug reactions

Project Summary/Abstract
Idiosyncratic adverse drug reactions (IADRs) occur in a small but significant percentage of the population, are
unpredictable, and frequently cause life-threatening events requiring intensive medical care. IADRs are typically
only discovered late in drug development, or after a drug is approved and widely available. Most IADRs are
presumed to be immune mediated. Genetic predisposition has been identified as a risk factor in some IADRs
with specific human leukocyte antigen (HLA) alleles associated with specific IADRs. A single drug can cause
strikingly different IADR phenotypes and be linked with different HLA markers based on phenotype. Drug
metabolism has also been an important focus of IADR etiology. Reactivity of drug metabolites as measured by
the formation of protein adducts correlates with the tendency of a drug to cause an IADR. Reactive metabolites
have been implicated in forming haptens and activating antigen-presenting cells, yet few studies investigate the
interface between drug metabolites and immune-mediated reactions. We plan to leverage our prior work to build
an integrative research platform that addresses multiple factors involved in the development of IADRs.
We will focus our research on trimethoprim-sulfamethoxazole (TMP-SMX) IADRs given our group’s extensive
experience with this drug. TMP-SMX is a commonly used antibiotic and is associated with unpredictable, life-
threatening IADRs including severe skin, liver, and lung injury. Our goal is to combine metabolism, genetics and
immune signaling studies to identify putative biomarkers for TMP-SMX IADRs. Our approach includes identifying
tissue specific metabolites to evaluate how these molecules interact with immune pathways and antigen
presentation. We plan to 1) identify high risk metabolites based upon abundance, reactivity and tissue specificity,
2) use the identified metabolites to probe immune pathway responses, 3) determine the influence of selected
metabolites on HLA peptide presentation. Through the integration of drug metabolism, immune signaling, and
HLA antigen presentation, we will gain a greater understanding of IADR biomarkers and mechanistic insight. Our
overall vision of this research program is that our multi-pronged approach will enhance IADR research resulting
in the safer use of drugs.

Public health relevance
Project Narrative Idiosyncratic adverse drug reactions (IADRs) pose serious health and economic burdens. Many of the underlying causes of IADRs are poorly understood as mechanistic models are limited, and drug reactions are unpredictable and have variable phenotypes. For this program, we will build a research platform to incorporate results from drug metabolism, metabolite reactivity, immunological and genetic assays to define IADR mechanisms and discover biomarkers that can be utilized clinically to avoid future adverse reactions.